A Phenotypical Brain Organoids for Neurodevelopmental Disorders

PROJECT SUMMARY/ABSTRACT
Neurodevelopmental disorders (NDDs) are characterized by disrupted development of the brain, and clinically
they lead to impaired neurological function. NDDs account for ~25% of chronic pediatric disease, are incurable
and result in lifelong impairments. Molecular studies have improved our understanding of NDDs, but still large
gaps in knowledge exist. Conventional research tools like the mouse model does not often adequately model
these conditions. Human brain organoids (hBOs) from patient-derived iPSCs can capture many characteristics
and biological events in the developing brain. However, we still do not know how well human NDDs can be
modeled in hBOs. Here, I propose to investigate the range of genotype-phenotype correlations observable in
hBOs from a unique patient derived iPSC library of 750 independent lines to test four hypotheses: 1] NDD-
derived hBOs are both sensitive and specific detectors of the underlying clinical brain pathology. 2] NDD-derived
hBOs show both cellular and molecular hallmarks revealing the stages of disrupted brain development. 3]
Omics approaches applied to these in-vitro derived hBOs can reveal underlying mechanisms of
disrupted development. 4] Gene-environment interactions can be interrogated in hBOs.
The training phase of the award, conducted in Dr. Gleeson’s lab at UCSD, outlines a comprehensive plan for
acquisition of technical and professional skills that will enable my transition to an independent research
position. The successful completion of this project will provide a platform for future experiments aimed to
combine my expertise in stem cell fate decision to gain a deeper understanding of how does these
transcriptional, epigenetic and structural specificities contribute to neurodevelopmental brain disorders.

Public health relevance
PROJECT NARRATIVE Neurodevelopmental disorders are characterized by disrupted development of the brain, and clinically by impaired neurological function. Molecular studies have improved our understanding of NDDs, but still large gaps in knowledge remain. Combinations of state of the art brain organoid modeling and transcriptional/epigenetic profile analysis can demonstrate fingerprints for individual NDDs, and provide reliable patient-specific’ avatars’ for precision therapies. Here I propose to develop the first NDD phenotypic and molecular atlas, to link clinical diagnosis with disease models. This work has the potential to shift how people think about neurodevelopmental disease and the path to therapy.